In vivo Studies of Creatine Kinase Kinetics by 31P Magnetization Transfer MRS

DESCRIPTION (provided by applicant): Cardiovascular disease is the leading cause of death in the U.S. despite improvements in prevention, detection, and treatment. Although the cause of heart failure is multi-factorial, there is increasing evidence that a mismatch in myocardial energy supply and demand contributes to the development of left ventricular dysfunction. Heart uses chemical energy in the form of adenosine triphosphate (ATP) to support systolic and diastolic function. The creatine kinase (CK) system acts as the primary ATP reserve for the heart and instantaneously supplies ATP for its contractile function. Changes in the CK system are seen in heart failure in both the human and animal myocardium indicative of impaired delivery of ATP to energy consuming systems. Therefore it is logical to hypothesize that the development of new noninvasive quantitative methods for serial studies of energy metabolism would be especially valuable for enhancing our understanding of the development and progression of heart failure. Magnetization transfer phosphorous-31 magnetic resonance spectroscopy (MRS) is an ideal tool to measure the kinetics of high energy phosphate metabolism in living tissue, and has been used for such in isolated heart preparations and open chest animal experiments. Methods for in vivo CK flux measurements in hearts have been lagging because of the sensitivity and complexity of the technique. The major problems arise from long examination time and signal contamination from the skeletal muscles in chest wall, which is further exacerbated by respiratory motion. A new approach to measure in vivo CK flux, overcoming the issues of lengthy examination time will be developed. Coupled with novel approach to eliminate signal contamination from the chest muscles using inhomogeneous magnetic field gradient surface spoiling will lead to clinically useful MRS technique to quantify myocardial CK flux in vivo and, thus provide accurate evaluation of energy metabolite turnover in the heart. The initial technique development will focus on small animal experiments and the results will be compared to open chest experiments to evaluate the accuracy of the technique. In vivo sensitivity of the technique will be established using a diabetic rat heart model where CK flux is expected to vary over a large range. Correlations will be obtained with the biochemical measurements of CK isoenzyme. The research project will conclude with the development and feasibility testing of the technique for clinical research.

Public health relevance
PUBLIC HEALTH RELEVANCE (provided by applicant): Obesity, diabetes and related complications especially cardiovascular disease are a huge burden on individuals in particular and US economy in general. Development of new and improved techniques to understand in vivo metabolism and generate new knowledge will be of paramount importance to understand, diagnose, treat and manage these complications. The proposed project aims to develop new methodology to measure and understand energy disorders in cardiovascular disease and the techniques developed will be critically useful to advance basic research and medical care. Obesity, diabetes and related complications especially cardiovascular disease are a huge burden on individuals in particular and US economy in general. Development of new and improved techniques to understand in vivo metabolism and generate new knowledge will be of paramount importance to understand, diagnose, treat and manage these complications. The proposed project aims to develop new methodology to measure and understand energy disorders in cardiovascular disease and the techniques developed will be critically useful to advance basic research and medical care. __SpecificAimsTextDelimiter__ A: Specific Aims Heart uses chemical energy in the form of adenosine triphosphate (ATP) for its systolic and diastolic functions. The amount of ATP stored in the heart is small therefore relatively large rates of ATP synthesis and transport are required for normal cardiac function. Myocardium has high levels of creatine kinase (CK) isoenzymes, which catalyzes the reversible exchange of phosphocreatine (PCr) and ATP. Hence, it acts as an energy reserve and transport mechanism, ensuring that there is an abundant and immediate ATP production for contractile work (1). Phosphorous (31P) magnetic resonance spectroscopy (MRS) is currently used as a non-invasive tool to measure the ratio of PCr to ATP as an index of cardiac energy metabolism. However, this approach has yielded conflicting results in various human and animal models of heart failure, suggesting that the PCr to ATP ratio is not be a reliable indicator of cardiac function or metabolic state (2-8). Changes in the CK system are seen in heart failure in both the human and animal myocardium indicative of impaired delivery of ATP to energy consuming systems (9,10). Magnetization transfer magnetic resonance spectroscopy has been used to investigate high energy phosphate turnover in isolated heart preparations. Evidence from these studies suggests that a quantitative measure of CK flux provides a better measure of cardiac energy metabolism than the PCr to ATP ratio (11-15). Considering the results from these studies, we hypothesize that in vivo determination of CK reaction kinetics will be a robust measure of myocardial metabolism and provide critically needed data for better understanding energy metabolism and left ventricular dysfunction and heart failure. Methods for in vivo CK flux measurements in hearts have been lagging because of the sensitivity and complexity of the technique. The major problems arise from long examination time and signal contamination from the skeletal muscles in chest wall, which is further exacerbated by respiratory motion. We propose a modified approach to measure in vivo CK flux, overcoming the issues of lengthy examination time. We also propose a new approach to eliminate signal contamination from the chest muscles using inhomogeneous magnetic field gradient surface spoiling ideally suited for free breathing studies. The initial technique development will focus on small animal experiments and the results will be compared to open chest experiments to evaluate the accuracy of the technique. Then we will use a diabetic rat heart model to test the sensitivity of the technique because it has been demonstrated that CK activity can decrease by 80% in diabetic heart. Correlations will be obtained with the biochemical measurements of CK isoenzyme. The research project will conclude with the development and feasibility testing of the technique for clinical research. A.1: Specific Aim 1: To develop and validate a method to quantify high energy phosphate (HEP) turnover in myocardium in vivo using 31P magnetization transfer magnetic resonance spectroscopy. For this aim my focus will be on development of time efficient magnetization transfer technique to quantify CK flux for in vivo rat hearts. A new technique for signal localization from the heart will also be developed and tested by means of a meanderline gradient coil to selectively dephase the signal from the chest wall muscles using inhomogeneous magnetic field gradient surface-spoiling. This will allow uncontaminated signal from the heart during free breathing experiments thus further improving the efficiency of the technique. The quality of these in vivo results will be established by open chest animal experiments where the RF coil is placed directly over the heart. This setup ensures that the coil moves with the chest and the effect of motion and extraneous signals is minimized. Quantitative results from open chest experiments will serve as the gold standard for the in vivo flux measurement, establishing the accuracy of the technique. A.2: Specific Aim 2: Establish the sensitivity and feasibility of the newly developed method in specific aim 1 to monitors changes in CK flux. Previous biochemical and 31P NMR measurements have shown significant decrease in the total CK activity and CK flux in rat hearts after streptozotocin (STZ) induced diabetes. We will validate the sensitivity of the technique, in this model system, where the CK flux is expected to vary over a wide range. The optimized MRS technique will be cross-validated with biochemical measures (coupled enzyme systems) of total CK activity. This will also establish the feasibility of the technique to quantify energy metabolism as an early marker of diabetic cardiomyopathy. In order to evaluate the relative merit of our methodology, we will compare it to standard echocardiography index of heart function. A.3: Specific Aim 3: Implement the in vivo CK-flux measurement technique on human 3T scanner. We will further develop and implement the magnetization transfer method to measure CK flux for human clinical studies. The technique will be validated using normal subjects and subjects with LV dysfunction due to prior anterior wall myocardial infarction. This patient group was chosen because results of studies in animal models have consistently shown a decrease in CK flux and in humans a decrease in PCr and ATP concentrations and CK activity. Using these two subject groups we expect to see a significant decrease in CK flux in disease group. This will also establish the efficacy of the signal localization approach (i.e. using inhomogeneous magnetic field gradient surface-spoiling) since chest muscles CK flux in not expected to be different in these two groups. The overall sensitivity will be established by comparing the results with and without localization.